Use of Bacteriophages to Prevent, Diagnose, and Treat Diseases

The extracellular domain of EGFRvIII was displayed on Lambda virion by genetic fusion of the EGFRvII peptide to Lambda head protein D. Upon administration of the this Lambda virion into experimental mice, it generated mice serum which specifically interct with EGFRvIII protein but not with wildtype EGFR . The serum The specificity tests were performed by ELISA assays and Western Blot experiments. These results provide strong evidence that our EGFRvIII phage display system has high potential to act as vaccines in EGFRvIII cancers. We would like to follow tumor regression in mouse models with experimental EGFRviii Glioblastoma using the phage-based potential EGFRvIII vaccine